Pathology and Tissue Informatics Core

PROJECT SUMMARY/ABSTRACT: PATHOLOGY AND TISSUE INFORMATICS CORE
The Pathology and Tissue Informatics Core (PTIC) combines a centralized mechanism for expert tissue handling
services and performance of tissue-based assays by highly qualified, experienced personnel with a state-of-the-
art integrated informatics infrastructure which provides tools for 1) scheduling and tracking specimen collection,
2) histopathological and clinical annotation of acquired samples including virtual slide images and 3) maintaining
linkage of genomic and other resultant translational data generated by Projects 1 through 4 proposed in this
renewal with these samples. The PTIC will consent, collect, de-identify, process, bank and distribute annotated,
high-quality breast tumor, blood and urine samples from patients participating in SPORE clinical trials and/or
enrolled in the Vanderbilt Breast Tissue/Body Fluids Repository protocol, while protecting patient confidentiality
by de-identification of specimens upon distribution. The PITC will provide investigators with specialized technical
and interpretative histology services including expertise in developing, performing and evaluating
immunohistochemistry (IHC) and fluorescence in situ hybridization (FISH) assays, TIL assessments, tissue Q/A
and preparation for nucleic acid extraction for sequencing-based assays and oversight on optimal utilization of
each sample. Partnering of tissue services and Vanderbilt-Ingram Cancer Center (VICC) Research Informatics
Shared Resource (RISR) unifies the expertise required to create the Triple Negative Breast Cancer (TNBC) Atlas
Collaborative, a unique resource focused on TNBC cases interrogated in this renewal as well as prior SPORE
grant cycles, that integrates translational data generated in multiple systems into a comprehensive resource of
over 500 TNBC cases with subsequent local and public dissemination for secondary use of research data
including submission to the American Association for Cancer Research (AACR) Project GENIE and NCI
Genomic Data Commons (GDC).

Public health relevance
PROJECT NARRATIVE: PATHOLOGY AND TISSUE INFORMATICS CORE The Pathology and Tissue Informatics Core (PTIC) is critical to the mission of Vanderbilt-Ingram Cancer Center (VICC) SPORE in Breast Cancer. This resource is devoted to clinical trial-related tissue collection, procurement for the Vanderbilt Breast Tissue and Body Fluids Repository and provision of specialized diagnostic and technical histopathology services to SPORE investigators. Partnering of pathology tissue services and VICC Research Informatics Shared Resource (RISR) unifies the expertise required to schedule and track tissue collections; link specimen-specific information to subsequent translational genomic and protein expression data; and create the Triple Negative Breast Cancer (TNBC) Atlas Collaborative, a unique resource that will have greater than 375 metastatic triple negative breast cancer cases which will be publicly disseminated.